Dissemination Core

Project Summary/Abstract – Dissemination Core
A major function of the Center for the Advancement of Point-of-Care Technologies (CAPCaT) in heart, lung,
blood, and sleep (HLBS) disorders is to train innovators developing novel point-of-care and home-based
technologies; and disseminate both those technologies and insights about the product development process to
a wide group of stakeholders. HLBS disorders are the major cause of morbidity and mortality in the US, despite
decades of research and substantial improvements in treatments, prevention and outcomes. Health care is
undergoing a transformation in care delivery from medical centers and office-based settings to remote-monitoring
and home-based care. The development of POC will greatly facilitate and accelerate this transformation by: 1)
providing methods to monitor health/medical status in people as they go about their daily lives outside the clinic;
2) delivering actionable reports to the point of care; and 3) providing rapid feedback to caregivers and patients
to improve patient self-care, symptom detection, diagnosis, and treatment delivery. POCT product development
is challenging because of the need to integrate disparate disciplines such as human biology, engineering,
software, and device development. New models are emerging in both academia and industry to implement cross-
functional development teams and to speed the translational process. A key element of success is the
development of novel training programs to expose POC developers and users to the clinical and process issues
related to device development, validation and commercialization. CAPCaT will develop and lead innovative
teaching programs and leverage complementary educational opportunities to provide a comprehensive training
and dissemination plan for the POC development community. Highlights of this program will include a short-
course modeled on the I-Corps program, a dynamic educational series on the clinical and process elements of
POC development, and an annual stakeholder showcase day. The knowledge generated through these
programs will, in turn, be used to inform other core activities of CAPCaT.